Understanding the antiviral roles of acellular RNA quality control pathway

Abstract
Eukaryotic cells use multi-layered strategies to ensure the fidelity of gene expression. One of the best-studied
RNA quality control pathways is Nonsense-mediated mRNA decay (NMD), a ribosome-associated surveillance
machinery that recognizes and degrades cellular transcripts with premature termination codons (PTC). Initially
identified as a mechanism to rid the cell of faulty mRNAs, it is now known that NMD also regulates the expression
of 5-10% of cellular transcripts with important functions in cell differentiation, homeostasis, cellular stress
responses, and more. In addition, recent studies have shown that many proteins of the NMD pathway function
in the cell-autonomous defense against RNA viruses, including human-pathogenic alphaviruses, coronaviruses
and flaviviruses. As obligate intracellular parasites, these viruses interface closely with cellular mRNA processing
pathways, and we can gain new insight to NMD functions by understanding how the machinery is repurposed to
fight viral infection. We currently have a very incomplete picture of NMD functions during viral infection. Many
viruses lack PTCs or other NMD-inducing features, and it is not known whether NMD proteins recognize viral
RNA in manners similar to canonical NMD, or through new and unusual interactions or mechanisms. Moreover,
NMD is often globally downregulated during virus infection, suggesting that viruses have mechanisms to rewire
the antiviral NMD network. Using the flavivirus Zika virus (ZIKV) as a model RNA virus, we aim to understand
the molecular interactions between the NMD machinery and viral infection. We will dissect the NMD-ZIKV
protein-protein and protein-RNA interaction network with a multi-disciplinary approach that combines virology
with RNA biochemistry and high-throughput assays to link molecular interactions to cellular phenotypes. Specific
questions addressed within this study are: 1) How do NMD proteins interact to fight viral infection? 2) Are there
specific features in the viral RNA that trigger NMD, and if so, how are they recognized by the NMD machinery?
3) How do viral proteins inhibit NMD? And 4) Are antiviral NMD functions conserved in the important mosquito
host of flaviviruses? Collectively, our study will provide new insight into an important cell-autonomous antiviral
defense network. In addition, by studying the unusual ways in which NMD is regulated during virus infection, we
hope to discover new cellular functions of the NMD machinery itself.

Public health relevance
Narrative All eukaryotic cells use the RNA quality control pathways Nonsense-mediated mRNA decay to recognize and degrade faulty transcripts. NMD also restricts the infection with many RNA viruses, but the mechanisms of antiviral NMD are poorly understood. We seek to uncover the protein-protein and protein-RNA interaction network behind antiviral NMD, with the goal to gain new insight into cell-autonomous antiviral defense strategies and cellular gene regulation control.